PETER KUHN PRT-STRUCTURAL PROTEOMICS OF SMALL PROTEOMES

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Research focuses on protein structure determination aiding drug discovery and functional proteomics. We anticipate to utilize SMB resources for crystal screening and structure determination of crystals from membrane proteins and proteins from the SARS Coronavirus.